Southern California Research Center for ALPD and Cirrhosis

OVERALL - SUMMARY
Alcohol-associated liver and pancreatic diseases (ALPD) and cirrhosis constitute leading metabolic diseases
caused by alcohol use disorder around the globe. The Southern California Research Center for ALPD and
Cirrhosis unifies 60 investigators from six academic institutions in Southern California to pursue a common
mission of being a leader in research, training, outreach, and treatment for the diseases. The center, since its
inception in 1999, has devoted its efforts for development and use of clinically relevant animal models to gain
novel insights into the molecular mechanisms of ALPD and cirrhosis. These efforts culminated to
groundbreaking discoveries and new therapeutic developments for the diseases such as a phage cocktail to
treat alcohol-associated hepatitis patients with cytolysin-positive E. faecalis, anti-IL-23 monoclonal antibody
for patients with alcohol-associated liver disease, and Simvastatin for treatment of recurrent acute pancreatitis.
The center’s interactive infrastructure and environment have facilitated in the past 5 years: a 134% increase
in research base to $21.6M/year; 11 new U01/P01/MPI-R01 programs and 3 DOD program projects; 241
publications; 8 NIH/DOD-funded early-stage investigators; 14 postdocs transitioned to faculty positions at US
universities; 99 graduate students taught and 44 students undergone the Lee Summer Research Fellowship;
and 4 workshop/community seminars and 4 international symposia organized. As a unique national resource,
the center has supported 15 non-center investigators via provision of 383 model mice and 333 biospecimens
by the Animal Core, facilitating their 13 grant acquisitions and applications. We further consolidated the
regional repository resources to advance our ALPD translational and clinical studies in pursuit for novel
therapeutic modalities.
The center will continue to strive as a unique national scientific center of excellence in ALPD and cirrhosis by:
1) maximizing our interactive and synergistic science for a pursuit for the center’s main goal of identification
of therapeutic targets for advanced ALPD and cirrhosis;
2) serving as a national and international resource in our fields of research via provision of unique models,
technology, expertise, and collaborative opportunities with outside NIAAA-funded scientists;
3) providing comprehensive education and training at the multi-levels ranging from undergraduate and
graduate students, postdoctoral trainees, to junior scientists and faculty to foster and support future
generations of independent scientists in the ALPD and cirrhosis field; and
4) continuing outreach efforts to disseminate the center’s new findings to lay public, healthcare workers, and
scientists in our home and global communities.

Public health relevance
OVERALL - NARRATIVE Alcohol-associated liver and pancreatic diseases (ALPD) and cirrhosis are the major medical consequences of excessive alcohol drinking with high mortality around the world. The Southern California Research Center for ALPD and Cirrhosis is a regional, multi-institutional and multi-disciplinary center which continues to strive for integrated and comprehensive efforts to advance research, education, training and dissemination on the diseases. In support of its mission, Administrative Core provides administrative and logistic support; Animal Core produces innovative animal models of ALPD and cirrhosis; and Pilot Project Core provides seed funds to early-career investigators who are aspired to pursue independent ALPD research. The Center also supports four leading-edge research projects to help understand: how gut viruses contribute to alcohol- associated liver disease (AALD); how liver cancer is promoted by metabolic reprogramming in AALD; what cellular and molecular events drive excessive liver scarring in AALD; and how alcohol causes pancreas damage and inflammation via cholesterol dysregulation. High-impact outcomes from these activities are improving our understanding of the diseases and facilitating developments of new preventive and therapeutic approaches while serving as a unique national resource of technical, intellectual and collaborative services to investigators across the nation.